Elucidating the epigenetic regulation of extracellular matrix and virus-induced fibroblast activation

PROJECT SUMMARY
While wound healing processes are vital for successful organismal tissue repair, failure to turn off these
mechanisms lead to the excessive accumulation of the extracellular matrix (ECM) and the development of
fibrosis. Although recent research is beginning to illuminate the circumstances that allow for fibrosis resolution,
most fibrotic conditions remain unresolved; resulting in organ failure or a predisposition to cancer. While the
triggers for fibrotic diseases fall within a handful of categories, including viral/bacterial infection, tissue damage,
and chemical insults, all induce the sustained activation of mesenchymal cells into myofibroblasts. Besides
transforming growth factor β (TGF-β), which is a major activator of fibroblasts, the ECM also has the ability to
alter a fibroblast’s activation state. We and others have demonstrated that this activated phenotype can persist
despite the cell’s removal from fibrotic tissues, suggesting that fibroblasts have an “epigenetic memory” acquired
during activation and retained thereafter. However, the molecular details underlying epigenetic regulation during
myofibroblastic activation and whether these details are universal despite the activation trigger is unknown.
One potential mechanism of myofibroblast regulation is through the ECM-dependent expression of pro-
fibrotic genes. Gene expression is a tightly regulated process that requires chromatin remodeling, binding of
transcriptional activators, and recruitment of RNA polymerase to initiate transcription. As such, the structural
reorganization of the chromatin plays a large role in the temporal regulation and tissue specificity of gene
expression. Brahma-related gene 1 (BRG1) is a central catalytic ATP-subunit of the BAF (BRG1/BRM1-
associated factor) complex which works to drive chromatin accessibility via nucleosome eviction. BRG1 has also
been shown to regulate ECM gene expression in both healthy and virally-induced fibrotic contexts. Moreover,
preliminary data found that BRG1-deficient pancreatic fibroblasts lost the expression of a key functional
regulator, Netrin G1. Taken together, this suggests a role of BRG1 in regulating myofibroblast pro-fibrotic genes.
The overarching goal of this proposal is to test the hypothesis that the ECM and fibrosis-inducing viruses alter
fibroblasts’ chromatin landscape in a BRG1-dependent manner and contribute to the epigenetic memory that
underlies myofibroblastic function.
To test this hypothesis, Aim 1 will first investigate BRG1’s involvement in pancreatic fibroblast activation in
vitro and whether this is regulated by ECM-mediated signaling. In Aim 2, experiments will focus on the role of
BRG1 in regulating disease formation by using an in vivo pancreatitis mouse model. Finally, Aim 3 will build on
these lessons and investigate the mechanisms by which fibrosis-inducing viruses cause myofibroblast activation,
beginning with the frequent human pathogen, Influenza A virus. By using a novel perspective to understanding
fibrosis, this research provides insights that will advance cell biology, epigenetics, and virology, as well as reveal
how the ECM/viruses create a pro-fibrotic state.

Public health relevance
PROJECT NARRATIVE Fibrosis is the excessive accumulation of interstitial extracellular matrix (ECM) generated by activated fibroblasts and is a condition that can affect nearly every organ of the body. However, how activated fibroblasts are epigenetically regulated to maintain its activation and allow for pro-fibrotic gene expression is unclear. By elucidating how the ECM and fibrosis-inducing viruses alter fibroblasts’ chromatin landscape, this innovative study will expand our current understanding of how fibrotic disease develop, with the potential to uncover novel molecular linchpins that could serve as biomarkers or therapeutic targets in the future.